Resource competition drives natural and rebound dynamics of snails and schistosomes

RESOURCE COMPETITION DRIVES NATURAL AND REBOUND DYNAMICS OF SNAILS
AND SCHISTOSOMES
Project summary
More than 250 million people are infected with schistosomes, flatworms in the genus
Schistosoma, and 20 million humans suffer from severe morbidity due to schistosomiasis.
Humans become infected after exposure to larval parasites (cercariae) that are produced by
infected snails in freshwater habitats. Therefore, the production of cercariae by snail populations
represents an important component of the human risk of exposure, infection, and disease.
Schistosomiasis control incorporates many programs, including drug administration,
behavioral intervention and snail control. Snail control programs reduce snail density by
applying toxic chemical molluscicides or lethal predators. However, snails themselves do not
directly infect humans. Instead, snails release free living cercariae that directly cause human
infections following skin contact. This mismatch between the target of control (snails) and the
proximate cause of human infections (cercariae) complicates schistosome control because the
production of cercariae per snail is sensitive to ecological conditions, such as snail density.
The vast majority of models and control trials examining the natural dynamics and
control of schistosomes assume that snails are all equally infectious, leading to the assumption
that snail density directly correlates with cercariae density, and therefore potential for human
exposure. However, infected snails can produce >50-fold more cercariae when food is
abundant, competitors are scarce, and physical conditions are otherwise benign. Thus, counter
to conventional wisdom, cercarial densities, and human exposure potential, could be greatest
when the density of snails is lower and growing. Therefore, studying the dynamic link between
snail and cercarial density is critical to designing optimal snail control strategies, because these
dynamics determine the timing and magnitude of human risk.
This research will combine field and laboratory experiments to test novel hypotheses for
the dynamics of cercariae in natural settings that arise from theory we developed to explicitly
incorporate energy uptake and use by snails and schistosomes in dynamic scenarios.
Specifically, we will test predictions that: (1) there are brief, intense peaks of cercarial density
early in the season, when individual snails are large and highly reproductive, (2) the presence of
other food sources, such as decaying plants can sustain cercarial production over longer
periods, and (3) reducing, but not eliminating, snails from water bodies could backfire, causing
little reduction or even an increase in cercariae, by relaxing competition for food. Ultimately, this
work can improve the prediction and control of a parasite causing major global health burden.

Public health relevance
Project Narrative Currently, more than 250 million humans worldwide are infected with schistosomes, flatworms in the genus Schistosoma, and approximately 20 million humans suffer from severe morbidity due to schistosomiasis. Humans become infected after exposure to larval parasites (cercariae) that are produced by infected snails in freshwater habitats. This project proposes and evaluates novel ecological hypotheses that could improve the prediction and control of a parasite causing major global health burden.